Beyond Lysis: Deciphering the Role of Perforin-Mediated Ferroptosis in Anti-Tumor Immunity

Perforin, a crucial T cell protein, mediates tumor cell death by a poorly understood mechanism. This
proposal is based on preliminary data suggesting that perforin can induces ferroptosis in tumor cells by
increasing intracellular iron. Ferroptosis is a programmed cell death pathway dependent on iron and lipid
peroxidation. The long-term goal is to develop translational therapies to enhance perforin-induced ferroptosis.
The overall objective is to determine the mechanism and metabolic regulators of perforin-induced ferroptosis.
The central hypothesis is that perforin increases intracellular iron, triggering ferroptosis and inhibiting
metastasis and immunotherapy resistance. The central hypothesis will be tested by three specific aims: 1)
Define the molecular mechanisms of perforin-mediated ferroptosis; 2) Characterize the contribution of perforin-
induced ferroptosis to anti-tumor immunity; and 3) Determine the role of tumor metabolism in perforin-induced
ferroptosis (R00). Aim 1 will use genetic, pharmacologic, and dietary approaches to mechanistically define
perforin-induced ferroptosis. Aim 2 will study the role of perforin-induced ferroptosis in metastatic, primary, and
immunotherapy in vivo models. Aim 2 will also bioinformatically explore how perforin expression contributes to
patient immunotherapy response. Aim 3 will metabolically manipulate tumor cells to optimize perforin killing and
leverage translational chimeric antigen receptor-T cell (CAR-T) technology.
Together, this proposed research will elucidate the ferroptosis-inducing function of perforin and its
contribution to immunotherapy response and metastasis control in different metabolic contexts. The research
proposed in this application is innovative because it explores a previously unknown mechanism of perforin
killing molecularly, translationally, and metabolically. This innovative perspective on CTL-mediated tumor killing
has the potential to explain the role of in vivo immune-induced ferroptosis in immunotherapy response and lay
a foundation to explore novel cancer immunotherapies based on perforin-induced ferroptosis. This work will be
accomplished under the mentorship of Dr. Weiping Zou (tumor immunology) and Dr. Arul Chinnaiyan
(translational pathology) alongside a team of Michigan-based experts in immunology, bioinformatics, and
metabolism. A comprehensive training plan will provide technical training in mass spectrometry, flow
cytometry, bioinformatics, and CAR-T approaches. Attention will be given to facilitating training in mentorship,
project management, manuscript preparation and grantsmanship. This comprehensive mentorship plan will
facilitate a smooth transition to a position as an independent investigator focused on microenvironmental
determinants of immune-mediated cell death.

Public health relevance
Despite decades of concerted investigation, immunotherapy resistance emerges in most cancer patients. Overcoming this resistance remains an enormous clinical challenge due to the lack of basic understanding of T cell killing mechanisms. This proposal will investigate mechanistically how the T cell effector protein perforin induces a type of cell death known as ferroptosis, and explore the metabolic and microenvironmental determinants of perforin-induced tumor death.